Clinical Phenotyping and Disease Specific Sampling to Identify Non-coding RNAs for Human Therapeutics in PAD

Abstract
Peripheral arterial disease (PAD) is one of the major complications of systemic atherosclerosis where arterial
occlusions result in two major clinical manifestations: leg pain with walking/reduced walking ability (a condition
termed intermittent claudication, IC) or critical limb ischemia (CLI) with leg pain at rest, ischemic ulcers, and
patients that face a >10% risk/year of major amputation. No medical therapy exists to improve perfusion to the
ischemic limb in PAD and there remains a clear need to develop new treatments. The central dogma of
molecular biology states that DNA makes RNA and RNA makes protein. However, the vast majority of the
mammalian genome does not encode proteins. There are two types of non-coding RNAs: micro-RNA (miR)
and long non-coding (lncRNA) RNAs. The diversity of miRs across species is far greater than encoded genes
and lncRNAs are an order of magnitude more diverse that miRs; this necessitates that strategies study human
disease. To that end, this proposal brings together a translational cardiovascular scientist who studies PAD
and whose work has included micro-RNAs (Annex), a research scientist who focuses on in-vitro and in-vivo
models of PAD (Ganta), a translational scientist who studies skeletal muscle adaptability to injury and has
developed an unparalleled biobank of human PAD tissues (McClung), as well as a computational biologist
(Keene) to provide bioinformatics analysis of RNA sequencing data. The central hypothesis of this proposal
states that condition specific sampling based on insights into the clinical disease condition from well-
phenotyped humans, bioinformatics analysis, and disease specific non-clinical testing will unlock non-coding
RNA novel human therapeutics. To that end, the Specific Aims are: 1: Identify miRs for therapeutic
modulation by determining differential expression in plasma across subjects with intermittent
claudication (IC) and critical limb ischemia (CLI) patients and age/sex-matched non-PAD control
subjects. Determine whether the ischemic skeletal muscle from the most symptomatic ischemic leg
demonstrates elevated expression of the miR. Candidate miR's will be examined through in-vitro studies in
PAD relevant conditions, through in-vivo efficacy. 2. Identify lncRNAs for modulation by determining the
differential expression of lncRNA in calf muscle from non-PAD and PAD (both IC and CLI) patients.
We will first look for lncRNA's that are up-regulated in PAD (IC and CLI) and will then examine whether up-
regulation occurs differentially (IC or CLI). In a new cohort, we will examine predictions form an initial list of
candidate lncRNAs and will determine whether target up-regulation also occurs in blood. 3) Utilize mouse
models of HLI that recapitulate the “major” differential for the IC vs. CLI designation in the human
condition to identify additional candidate lncRNAs that may be conserved from mouse to man and
serve as therapeutic candidates.

Public health relevance
Project Narrative – Public Health Relevance Peripheral arterial disease (PAD) is a major health problem that afflicts millions of patient in the United States. PAD is caused by atherosclerosis where blockages impair blood flow to the legs. PAD is crippling disease and there are no medical therapies that have the ability to improve blood flow to the legs of patients suffering from PAD. The central dogma of molecular biology states that DNA makes RNA and RNA makes protein. Yet, the vast majority of mammalian DNA does not encode any gene or genes. These regions are collectively call, non-coding RNAs which include both micro-RNAs and long non-coding RNAs. These molecules are now recognized as powerful factors that regulate the response to injury and thus are an important area for investigation. In general genes that encode proteins are well conserved along evolution but this is not the case for non-coding RNAs; thus the study of human material is critical for the study and plan. Non-coding RNAs carry out diverse functions without being translated into proteins. We will identify micro-RNA and lncRNAs that are altered in ischemic muscle and in peripheral blood of patients with peripheral arterial disease (PAD) to determine how they contribute to the disease phenotype and whether they can be developed into biomarker for diagnosis of PAD. This project will identify the mechanisms of action of these new regulators of disease and open the door for future therapeutic strategies that use or manipulate the non-coding RNAs for treatment of PAD.